Medication development of agonist-type treatment agents for stimulant addiction

Summary- Significant progress was made on this project, which involves the development of medications for psychiatric diseases. Three papers were published in peer-reviewed journals. In one notable article, we report that increasing the size of the N-alkyl substituent on the compound 4-methylamphetamine converts the drug from a dopamine transporter releaser into a dopamine transporter blocker. These results were published in the context of studying new drugs of abuse, but the findings have ramifications for designing new therapeutic drugs which target transporters. Specifically, the results demonstrate that increasing steric bulk on the amine group of amphetamine-type compounds will render the drugs less apt to serve as substrate-type dopamine releasers, thereby reducing their tendency to produce adverse effects on monoaminergic systems. Clandestine chemists synthesize novel stimulant drugs by exploiting structural templates known to target monoamine transporters for dopamine, norepinephrine, and serotonin (DAT, NET, and SERT, respectively). 4-Methylamphetamine (4-MA) is an emerging drug of abuse that interacts with transporters, but limited structure-activity data are available for its analogs. Here we employed uptake and release assays in rat brain synaptosomes, voltage-clamp current measurements in cells expressing transporters, and calcium flux assays in cells coexpressing transporters and calcium channels to study the effects of increasing N-alkyl chain length of 4-MA on interactions at DAT, NET, and SERT. In addition, we performed intracranial self-stimulation in rats to understand how the chemical modifications affect abuse liability. All 4-MA analogs inhibited uptake at DAT, NET, and SERT, but lengthening the amine substituent from methyl to ethyl, propyl, and butyl produced a stepwise decrease in potency. N-methyl 4-MA was an efficacious substrate-type releaser at DAT that evoked an inward depolarizing current and calcium influx, whereas other analogs did not exhibit these effects. N-methyl and N-ethyl 4-MA were substrates at NET, whereas N-propyl and N-butyl 4-MA were not. All analogs acted as SERT substrates, though N-butyl 4-MA had very weak effects. Intracranial self-stimulation in rats showed that elongating the N-alkyl chain decreased abuse-related effects in vivo that appeared to parallel reductions in DAT activity. Overall, converging lines of evidence show that lengthening the N-alkyl substituent of 4-MA reduces potency to inhibit transporters, eliminates substrate activity at DAT and NET, and decreases abuse liability of the compounds.